PET ligand discovery for arginine vasopressin

Project Summary. The V1A-specific arginine vasopressin receptor has recently become the focus of CNS research
when an association between the receptor gene and autism spectrum disorder (ASD) is identified. Dysregulation of
V1A activity has been suggested as a fundamental mechanism underlying ASD pathophysiology. Recent studies
revealed that V1A antagonists can regulate the effect of the AVP hormone, thereby tackling a potential root cause of
ASD development. PET is capable of quantifying biochemical processes in vivo, and a suitable V1A PET ligand would
substantially improve our understanding of V1A-mediated AVP signaling under different pathophysiological conditions,
otherwise inaccessible by ex vivo (destructive) analysis, particularly in higher species. Quantification of V1A in living
brain by PET would provide the assessment of distribution and expression and target engagement of new V1A-
targeted neurotherapeutics. To date, no successful examples have been demonstrated to image V1A-specific AVP
for human use, representing a significant deficiency of our ability to study this target in vivo for V1A. Therefore, we
propose to develop a novel PET ligand that can fill this void, as the first translational imaging tool.
The PI has recently developed a novel V1A-specific AVP ligand [11C]PF-184563 at MGH in 2021. While this
compound showed high potency and excellent selectivity, it is not likely pursued due to low brain penetration. In our
2nd generation, we identified a lead molecule, V1A-214, which showed substantially-improved binding affinity and
excellent target selectivity among all other major CNS targets. An 11C-isotopologue of V1A-214 was synthesized and
preliminary PET imaging studies confirmed that we have overcome two major obstacles for V1A-specific PET ligand
development by achieving: 1) high brain uptake (>1 SUV) and 2) high target specificity validated by human V1A cell
lines and blocking studies in vivo, and heterogenous uptake consistent with V1A regions in the CNS. Though V1A-
214 is a promising lead molecule for the development of new V1A-targeted PET ligands, due to species difference,
further optimization for translational cross-species (naïve/humanized V1A mice and nonhuman primates) imaging
studies are sought to achieve optimal AVP (V1A subunit) quantification in the living brain for drug discovery and clinical
biomarker for ASD patients.
On the basis that V1A-214 serves a validated lead for medicinal chemistry optimization, as specific objectives, we
will design and prepare a focused library of V1A-specific antagonists amenable for labeling with 11C or 18F, and
evaluate their ability to quantify V1A-specific AVP activity and changes in cellular experiments, naïve and humanized
V1A mice and nonhuman primates, as well as autoradiography and biological validation in postmortem NHP/human
brain tissues. The impact of this work is not only to develop the first successful high-affinity and selective V1A-specific
PET ligand for the study of ASD-related biological processes, but also ultimately, via PET imaging validation in higher
species, to advance this ligand as a potential clinical biomarker and for monitoring target response of novel
therapeutics for neurodevelopmental diseases and neuropsychiatric disorders, including ASD.

Public health relevance
Project Narrative Positron Emission Tomography (PET) is a medical technique that creates images of biochemical processes occurring in vivo, where radioactive molecules (also known as PET ligands) are injected and the distributions of those molecules are measured using a PET scanner. As the burden of psychiatric illnesses in the United States and worldwide is high, there is a critical need to develop novel PET ligands to image vasopressin-related neuropsychiatric disorders, including autism spectrum disorder. This work will develop key tools designed to advance the scientific understanding of arginine vasopressin receptor 1A in the central nervous system and facilitate the discovery of neurotherapeutics.